Ambient air pollutants as determinants of disparities in Alzheimer's disease and co-existing morbidity

Abstract
Ambient air contaminants have been associated with higher risk of Alzheimer's disease (AD), related dementia
(ADRD), and cognitive impairment; however, how variations in air pollution levels contribute to geographic
disparities in AD/ADRD risk and what mechanisms underlay these contributions remains unclear. The results of
our parent grant showed that pre-existing arterial hypertension, diabetes mellitus, cerebrovascular, and chronic
kidney diseases have a strong impact on racial disparities in AD/ADRD risk. These diseases in turn are
associated with exposure to air contaminants, including particulate matter (PM2.5). The proposed one-year
project is supplemental to Aim 3 of our parent grant. It will quantitatively evaluate the contributions of variations
in PM2.5 levels to geographic disparities in AD/ADRD risk and survival via direct (exposure to PM2.5) and indirect
(through the effects on co-existing diseases) mechanisms and identify age-, sex-, and race/ethnicity-specific
populations at higher vulnerability to PM2.5 effects. The Aim of this project focuses on quantification of PM2.5
impacts and the role of co-existing diseases that are associated with higher AD risk on geographic disparities in
AD/ADRD incidence and survival. The methods of causal mediation and decomposition analyses developed in
our parent grant will be used to evaluate contributions of PM2.5 to disparities in AD/ADRD risk and patient survival
and to identify the role co-existing diseases play in generating in such disparities. Traditional empiric and
regression approaches, propensity-score based methods, and other methods of causal analysis will be used for
quantifying the association between PM2.5 and AD/ADRD and to identify associated causal mechanisms. The
Oaxaca-Blinder approach generalized for use of time-to-event data and the causal mediation analyses for binary
mediators and time-to-event outcomes will be applied to explain the observed geographic disparities in terms of
predictors. The expected outcome will provide quantitative information on the contribution of ambient PM2.5 to
geographic disparities in AD/ADRD risk and survival in the U.S. population of older adults with specific focus on
highly vulnerable population groups. This study will assess 1) if a small reduction of PM levels (that may not
have visible impact on an individual level) can substantially reduce AD/ADRD risk on a population level; 2) if the
levels of ambient air contaminants that are below the World Health Organization (WHO) standards contribute to
increased risks of AD/ADRD; 3) which co-existing diseases contribute most to AD/ADRD risk through a PM2.5 -
related pathway; and 4) how improving the air quality in specific geographic areas can reduce geographic
disparities in AD/ADRD. The proposed research is relevant to the NIH/NIA mission and Strategic Directions for
Research 2020-2025 on understanding health disparities related to aging and developing strategies to improve
the health of older adults in diverse populations (Goal F).

Public health relevance
Narrative Currently available information on impacts of ambient air contaminants on Alzheimer's disease (AD) and related dementias (ADRD) risk is not sufficient to conclude on how they contribute to geographic disparities in AD/ADRD. To address this gap, the proposed study will leverage Medicare data and innovative statistical methods of causal analyses (piloted in the parent grant) to quantify direct (exposure to the air pollutant itself) and indirect (through the impacts of the air pollutant on diseases associated with higher AD/ADRD risk) effects on geographic disparities in AD/ADRD risk and identify highly vulnerable to these effects groups of the U.S. population.